Understanding and Exploiting Loss of Y in Cancer

PROJECT SUMMARY
My research as a physician-scientist has focused on the biology of bladder cancer (BC). I have translated this
knowledge into diagnostic and prognostic markers and novel therapeutic targets with the goal of improving
patient outcomes. My contributions include: identification of new growth and metastasis genes; description of
BC heterogeneity using single cell and spatial transcriptomics that provided clinically relevant stratification;
development of the “Molecular Twin”, an artificial intelligence (AI) platform that led to prognostic biomarkers
superior to those in standard of care; discovery of Ral GTPase inhibitors, targeting a protein considered
“undruggable”; and an in vivo functional genomic screen that discovered therapeutic targets enhancing
effectiveness of immune checkpoint blockade (ICB). My most recent discovery was made while investigating
why men have a higher incidence of BC than women, even though the latter experience more aggressive
disease. We found that aggressive forms of BC in men lose the Y chromosome and that this Loss Of
chromosome Y (LOY) drives BC growth while inducing T-cell exhaustion, which fortunately makes BC patients
with LOY more sensitive to ICB. Interestingly, LOY in peripheral blood mononuclear cells (PBMCs) is the most
common somatic genetic alteration in healthy men. This is associated with increased risk of BC and other
epithelial tumor types. We found a high proportion of LOY in CD4 and CD8 T-cells in the microenvironment of
human and murine BC tumors, and this independently correlated with poor outcomes. This was the first
demonstration that concomitant presence of LOY in immune cells and LOY cancer cells in tumor samples
adversely impacted prognosis. This led us to the hypothesis that urothelial and T-cell LOY conspire to promote
carcinogenesis and tumor progression while inducing tumor vulnerabilities. With BC as a clinically relevant model
to study LOY, we will use pioneering models and approaches we developed including novel genetically
engineered mice (GEM) with tissue-specific and inducible LOY to evaluate the impact of LOY in urothelial and
T-cells on carcinogenesis and progression. The impact of GEM-derived LOY T-cells and of human T-cells
generated from unique differentiated LOY-induced pluripotent stem cells (iPSCs) on in vivo growth of Y+/LOY
murine and human BC cells will be assessed, complementing GEM studies. Murine and human BC cell lines
coupled with functional genomic and high throughput small molecule screens will identify novel therapeutic
vulnerabilities of LOY cancer cells and LOY tumors. To validate results from models, we will evaluate LOY in
PBMCs, tissue, and urine, in diverse BC patient cohorts to understand the impact of LOY on bladder
carcinogenesis and patient outcomes and whether the impact is dependent on other patient characteristics such
as race, ethnicity, and treatment. While a nascent field, the clinical relevance of LOY offers new and untapped
opportunities to understand cancer. Our objective is to provide scientific insights into LOY biology that serve as
foundations for prevention, early detection, and therapeutic approaches in bladder and other cancer types.

Public health relevance
PROJECT NARRATIVE My research as a physician-scientist has focused on understanding bladder cancer biology and translating this knowledge into diagnostic and prognostic markers and therapies that improve patient outcomes. We discovered that Loss Of chromosome Y (LOY) in bladder tumors and tumor-infiltrating T-cells promotes tumor growth in mouse models and correlates with poor prognosis in patients, through exhaustion of anti-tumor T-cell response. Our objective is to determine how LOY in both normal and malignant cells drive bladder cancer development and progression and exploit those findings to establish new paradigms for detection, prevention, and treatment.